Cell specific & compartment specific changes in translation during long term memory storage

PROJECT ABSTRACT
In neurons, changes in transcription and translation are important processes underlying the process of long-term
potentiation at the synaptic level. However, the compartment-specific and cell-specific variations in translation
and transcription during the process of long-term memory (LTM) storage, along with the molecular mechanisms
responsible for these changes, remains unclear. Previous studies have found that mRNAs differentially localize
to different areas of the neuron and serve as the basis for localized translation via the actions of molecular motors,
such as kinesin and dynein. The importance of these motor proteins in the process of neuronal function is well-
documented, such that disruptions in the functions of these motors are associated with a range of
neurodegenerative diseases. Despite the importance of these proteins, the processes of translational control
that governs molecular motors during LTM remains poorly understood. This proposal seeks to understand this
relationship between local translation, molecular motors, and LTM storage, utilizing the model Aplysia californica.
Recent investigations into the role of axonal organelle transport during LTM identified enhanced bidirectional
transport of mitochondria associated with synapse maintenance. This enhancement in transport is dependent
upon translation and transcription. Building upon this finding, I hypothesize that compartment-specific regulations
of translation contributed to this change in transport, and play an important role in synapse formation,
maintenance, and plasticity. To test this hypothesis, puro-PLA will be used to examine the localized translation
of kinesins and dynein subunits, along with dynactin, using the Aplysia SN-L7 coculture system to reconstitute
synapses in vitro. In addition, puro-PLA will also be employed to examine the expression of translation regulators
such as eIFs, in order to elucidate the potential direct effects these regulators have on translation. Furthermore,
puromycin labelling will be used in conjunction to sensitization, tissue clearing and light-sheet microscopy to
assess temporal changes in translation at a cell-specific manner within the entire Aplysia CNS. These studies
will shed more light on the role of translational regulation in LTM, in both a simple circuitry and the entire nervous
system. The results of these studies will further elucidate the role of translational control in axonal transport
dysfunction that contribute to neurodegenerative diseases, and identify potential targets for therapeutic
development.

Public health relevance
PROJECT NARRATIVE Learning and memory is a basic yet important aspect of survival. Deficiencies in learning and memory caused by neurodegenerative diseases, dementias, and other neurological conditions have a serious and detrimental impact on a person’s quality of life. As a result, insight into the molecular mechanisms behind memory formation and storage can help improve the understanding we have of affected pathways during pathological conditions, and potentially develop therapeutics that could remedy or prevent the onset of these conditions.